Mechanisms of disease in patients with IκBα mutations

? DESCRIPTION (provided by applicant): Autosomal dominant ectodermal dysplasia with immune deficiency (AD ED-ID) is characterized by sparse hair, conical teeth, reduced number of sweat glands and susceptibility to severe infections. It is due to heterozygous mutations in IκBα that impair Ser32 and Ser26 phosphorylation and subsequent degradation of the mutant protein following receptor signaling. The non-degraded mutant protein accumulates and sequesters the p50 and p65 subunits of NFκB in the cytoplasm, impairing activation of the canonical NFκB pathway through a dominant negative (DN) effect. Our genotype-phenotype analysis of 9 patients with AD ED-ID indicates that disease severity and impairment of NFκB-dependent TLR-driven cytokine production are significantly worse in patients with IκBα point mutations than in those with N-terminal truncations. We hypothesize that the point mutants may be more stable than the truncation mutants, and thereby accumulate at a higher level, resulting in a stronger DN effect and more severe disease. Our analysis also shows that patients with AD ED-ID have a poor outcome after hematopoietic stem cell transplantation (HSCT) despite good donor chimerism. We have created a knock-in mouse heterozygous for the IκBα S32I mutation that recapitulates the phenotype of patients with AD ED-ID, The S32I mouse fails to develop contact hypersensitivity (CHS) or produce antibodies. Strikingly, the mutant completely lacks secondary lymphoid organs including lymph nodes and Peyer's patches, and fails to form germinal centers (GCs), two features typical of defective non-canonical NFκB signaling that were not previously recognized in AD ED-ID patients. LTβR-driven induction of chemokines and adhesion molecules mediated by both canonical and non-canonical NFκB pathways was impaired, and the levels of p100, a component of the non-canonical NFκB pathway, were markedly diminished in the mutant. IκBα mutant->Rag2-/-, but not WT->IκBα mutant, bone marrow chimeras formed proper lymphoid organs, developed CHS and formed GCs. These results suggest that defective architectural cell function underlies the immunodeficiency and poor outcome of HSCT in patients with IκBα mutations, and that correction of this niche may be critical for reconstituting their immune function. We propose to test the hypothesis that the stability of the IκBα mutant protein inversely correlates with the residual NFκB activity and th level of p100 in the patient cells, and thus determines disease severity and the outcome of HSCT. We will test the hypothesis that mesenchymal stem cells (MSCs) from mice with the S32I IκBα mutation have reduced p100 levels and impaired response to LTβR ligation, and to evaluate implantation of WT MSCs as a potential therapeutic strategy in a preclinical model for AD ED-ID.

Public health relevance
PUBLIC HEALTH RELEVANCE: Autosomal dominant ectodermal dysplasia with immune deficiency (AD ED-ID) is characterized by sparse hair, conical teeth, reduced number of sweat glands and susceptibility to severe infections. It is due to heterozygous mutations in IκBα that impair activation of the DNA transcription factor NFκB, which is essential for the expression of many immune defense genes. The outcome of allogeneic bone marrow transplantation (BMT) in AD ED-ID has been poor. A better understanding of the pathogenesis of AD ED-ID is critical for its effective treatment. Using a mouse model of AD ED-ID, we have demonstrated that there is a failure of non-immune stromal scaffolding cells to nucleate the formation of lymphoid structures, such as lymph nodes, which are essential for the generation of an immune response. Our findings suggest that failure to generate lymphoid organs strongly contributes to the immune deficiency in AD ED-ID, and explains the poor results obtained with BMT. The studies we propose will delineate the impact of IκBα mutations on immune function, predict the outcome of BMT, and evaluate the use of mesenchymal stem cells as a potential strategy aimed at correcting the stromal cell defect in patients with AD ED-ID. The results will be relevant to other PIDs where the genetic defect may affect stromal cells.